Development of Drugs Acting at Adenosine Receptors

Our laboratory has been one of the most active sources of new AR ligands that have therapeutic potential, and we are careful to cover promising discoveries with patent applications to safeguard the interest of public health and to facilitate translational medicine. Furthermore, we have designed and synthesized many ligands that are used widely in research. Synthetic selective ligands that either mimic the action of adenosine (i.e. agonists) in a fashion specific at a single subtype, or suppress it (i.e. antagonists), can be applied with great benefit in models of disease states, and therefore such agents are being explored as potential pharmaceuticals. For example, in the brain area for movement control (striatum), natural adenosine acting at postsynaptic A2A receptors opposes dopamine effects. In Parkinsons Disease, one would like to blockade this receptor to boost the dopaminergic signaling. This approach of using a selective AR antagonist to benefit patients suffering from a neurodegenerative disease is currently the focus of clinical trials. On the other hand, AR agonists are more applicable to disease treatment, e.g. in inflammatory diseases and cardioprotection. Thus, we are constantly searching for the most viable disease targets and translational opportunities for our technology. Our collaborations include studies of the role of ARs in the central nervous system, inflammatory/immune system, cardiovascular system, skeletal muscle, and other systems. A structural understanding of the molecular recognition and activation of the ARs is an important component of our studies that leads to novel ligands. We also use nuclear magnetic resonance to follow the signaling path within the A2A AR. The more that is known about the 3-dimensional structure of the target receptor, the easier it is to design appropriate ligands. In that regard, we have made significant advances in the approaches to structure-based discovery of small molecular ligands of ARs. In principle, this will allow future research to design more effective agonists of the ARs with fewer side effects due to high specificity for a particular receptor subtype. The rational design of AR ligands was greatly advanced by the recent elucidation of both the agonist-bound (activated) and antagonist-bound (inactive) states of the A2AAR. We have collaborated for X-ray crystallography of membrane-bound proteins with the lab of Prof. Ray Stevens of the Scripps Research Inst., to report the first X-ray structure of an agonist-bound A2AAR. We are now using this structure advantageously for in silico screening to discover new chemically diverse ligands and to modify existing ligands in ways made possible only through a detailed understanding of molecular recognition and activation of the receptor. This computerized process to discover new potential pharmaceuticals still requires chemical synthesis of target compounds to validate the structural hypotheses. We have introduced the first caged A2A antagonist, as a proof of principle of GPCR photopharmacology and demonstrated its efficacy in mouse models. Our novel selective A3AR agonists and antagonists containing a methanocarba (bicyclo3.1.0hexane) ribose-ring substitution constrained in the receptor-preferred North (N) conformation have improved pharmacological profiles. Also, at the A1AR, (N)-methanocarba nucleosides were truncated to eliminate 5-CH2OH with partial or full retention of agonism. Truncated derivatives have more drug-like physical properties; this approach is appealing for preclinical development of nucleoside analogues. Our ongoing program to develop selective A3AR agonists has resulted in advanced clinical trials of two nucleosides. Therapeutic interests related to selective ligands for the A3AR are anti-inflammatory, anti-ischemic (e.g. in the heart, brain, lungs, and skeletal muscle) and anticancer, by molecular mechanisms that entail modulation of the Wnt and the NF-kB signal transduction pathways. The A3AR is overexpressed in inflammatory and cancer cells, while low expression is found in normal cells, rendering the A3AR as a potential therapeutic target. Currently, A3AR agonists discovered in our lab (IB-MECA and Cl-IB-MECA) are developed for the treatment of inflammatory diseases including rheumatoid arthritis and psoriasis, and liver diseases such as hepatocellular carcinoma and NASH. Oral administration of IB-MECA for 12 weeks to patients with moderate-to-severe dry eye syndrome resulted in a statistically significant improvement in the mean change in clinical indicators, such as corneal staining, from baseline at week 12 in the treated group compared to placebo. A2BAR blockade inhibits growth of prostate cancer cells, suggesting selective A2BAR antagonists as cancer therapeutics. Another means of lowering adenosine in a tumor is to inhibit the enzyme CD73, and we have novel nucleotide inhibitors. Sterically constrained ((N)-methanocarba) adenosine derivatives were nanomolar full agonists of the A3AR and highly selective (>3000-fold). Combined 2-arylethynyl-N6-3-chlorobenzyl substitutions preserved A3AR affinity/selectivity (e.g., 3,4-difluorophenylethynyl full agonist MRS5698). Receptor docking identified a large, mainly hydrophobic arylethynyl binding region and a predicted helical rearrangement requiring an agonist-specific outward displacement of TM2 resembling opsin. Thus, the X-ray structure of related A2AAR is useful in guiding the design of new A3AR agonists. In collaboration with Daniela Salvemini, we have shown encouraging protective activity of A3AR agonists in models of chronic neuropathic pain. A3AR agonists suppress or prevent the development of chronic neuropathic pain in mice following chronic constriction injury or cancer chemotherapeutic agents (by both central and peripheral mechanisms). Agents tested include widely used drugs in three different classes. These effects were naloxone insensitive and thus were not opioid receptor mediated. MRS5698 was more potent and efficacious than morphine. In addition, MRS5698 was equally as efficacious as gabapentin or amitriptyline, but more potent. Besides its potent standalone ability to reverse established mechanoallodynia, MRS5698 significantly increased the antiallodynic effects of all 3 analgesics. If used therapeutically, this could facilitate the life-saving use of cancer chemotherapy, which often has to be limited or discontinued because of severe side effects such as pain. We use phenotypic in vivo screen for our new analogues. Another promising application of AR ligands is the use of A3AR antagonists for topical application in the treatment of glaucoma. Certain A3AR antagonists from our lab and outside collaborations are licensed for development as antiglaucoma agents. We have discovered positive allosteric modulators (PAMs) of the A3AR such as imidazoquinolinamines to modulate the actions of endogenous adenosine, potentially with fewer side effects than directly acting orthosteric agonists. The objective was to magnify the beneficial effects of the endogenous adenosine released during stress conditions. These effects of the PAMs would be event-specific within the body, i.e. the PAM would have no biological effect on its own unless adenosine was locally elevated. A1 agonists that act selectively in the brain are sought as cerebroprotective and anticonvulsant agents. Most known A1 receptor agonists display unacceptable side effects due to their peripheral action, such as alteration of heart rate and blood pressure. We have recently discovered, using a rational design process based on computer modeling, one such drug-like compound (MRS5474) that has the proper physicochemical properties to act at the desired site in the body. We also design and synthesize adenosine kinase inhibitors (to increase adenosine) for studies of their anti-epileptogenic activity.